TASK ORDER #75N92019F00075, PERIOD OF PERFORMANCE: 8/15/19-12/18/19, CAN 9-8470187

The Multi-Ethnic Study of Atherosclerosis was initiated in 1999 to study the correlates, predictors, and progression of subclinical CVD in a diverse population-based sample of men and women aged 45-64 who had no evidence of CVD at baseline.